Yale Alzheimer Disease Research Center

PROJECT SUMMARY: OVERALL YALE ADRC
The Yale Alzheimer’s Disease Research Center (ADRC) seeks to advance our understanding of
Alzheimer’s disease at a cell biological level with the eventual goal of translating laboratory discoveries into
novel effective clinical therapies. Seven Cores (Administrative, Clinical, Data, Biomarker, Neuropathology,
Imaging and Outreach) and a Research Education Component will work together to achieve this goal. Our
unifying theme is a focus on the cell biology of specific neurons, and its disruption in AD, whether measured by
genome/proteome-wide methods in Biofluids, imaged diagnostically, manifested clinically in behavioral
attributes, detected pathologically in brain tissue at autopsy or observed in cultures of induced pluripotent stem
cells. The participation of the seven Cores will accelerate and optimize the ability of individual Research
Projects both within and beyond the Yale ADRC to ask and answer specific pathophysiological questions and
to translate knowledge to therapies. The breadth of the Core support for particular projects will allow
assessments across the heterogeneity of Alzheimer’s disease.
The Yale ADRC expects to extend its track record of facilitating Research Projects focused on specific
neuronal organelles and specific neuronal subtypes perturbed in disease while making use of human tissue
analysis and human subject imaging to evaluate mechanistic hypotheses. The Biomarker Core will develop
novel, sensitive and high-throughput mass spectrometry assays and genomic methylation profiles to monitor
disease mechanisms. The Imaging Core will develop, integrate and apply novel PET tracers and functional
MRI connectivity maps to subjects of the Clinical Core and multiple separately supported Research Projects. A
key emphasis will be the translational development of research findings into therapeutic benefit. To support
the future strength of Alzheimer’s research, the Yale ADRC will strive to advance the careers of Young
Investigators through mentorship from a distinguished Internal Advisory Committee, and through Development
Project awards coupled with an extensive educational program developed by the Research Education
Component. In addition to collecting clinical data and biospecimens of brain, CSF, DNA, serum, blood cells
and iPSCs for analysis by members of the Yale ADRC research team, the Yale ADRC will support other NIH-
funded research studies on related topics and contribute materials to national NIA-sponsored research
networks. The Outreach Core will connect with the community to provide greater knowledge regarding
Alzheimer’s disease and related dementia.

Public health relevance
PROJECT NARRATIVE: OVERALL YALE ADRC The Yale Alzheimer Disease Research Center seeks to advance our understanding of Alzheimer’s disease with the eventual goal of translating laboratory discoveries into novel effective clinical therapies. Seven Cores (Administrative, Clinical, Data, Biomarker, Neuropathology, Imaging and Outreach) and a Research Education Component will work together to achieve this goal. Our unifying theme is a focus on the cell biology of specific neurons, and its heterogenous disruption in Alzheimer’s disease.